PHARMACOLOGICAL STUDIES OF SYNAPTIC TRANSMISSION IN VITRO

This Unit investigates the mechanism of action of excitatory amino acids as synaptic transmitters and neuromodulators in the vertebrate CNS, utilizing cell culture and electrophysiological techniques. Substantial progress has been made in developing a fast perfusion system for applying drugs and ions to nerve cells, and this is now used routinely. The divalent cations, zinc and cadmium, have two major effects on hippocampal neurons: (1) block of excitatory responses to NMDA receptors (Zinc Kd = 13 micromolars); (2) an increase in due to block of postsynaptic inhibitory GABA receptors (Zinc Kd = 11 micromolars), and zinc suppression of a transient potassium current, which normally slows repetitive firing. Zinc block of NMDA responses is reduced on raising the extracellular calcium concentration suggesting competition between zinc and calcium or screening of the zinc binding site by calcium. Low concentrations of zinc (50 micromolars) also potentiate responses to kainate, quisqualate, and response to glutamate at non-NMDA receptors. Fast application of excitatory amino acids produces three patterns of response: fast (tau = 20 ms) desensitization of quisqualate receptors: slow (tau = 200 ms) desensitization of NMDA receptors, sustained activation of kainate receptors. Concanavalin-A, which binds to glycoproteins, reduces desensitization at quisqualate but not NMDA receptors, and does not alter responses to kainate. Low concentrations of L- glutamate @ 1 micromolar) were found to depress excitatory synaptic transmission via activation of a novel presynaptic receptor: L-AP4 mimics this effect. Neither agonist produces a substantial postsynaptic response in glycine free medium. Culture medium is conditioned by substances secreted into the extracellular space, including L-glutamate, which tonically inhibits synaptic transmission; on the other hand neuronal survival in F-12 medium reflects activity of a glial sink for neurotoxic amino acids, which rapidly reduces the L-glutamate concentration from 100 less than 10 micromolars.